Project 2: The impact of biobehavioral factors and aspirin on ovarian cancer biology

Growing evidence indicates that the biological response to chronic stress and subsequent distress can promote
the progression of epithelial ovarian cancer via prolonged activation of the sympathetic nervous system and
sustained norepinephrine release. Downstream consequences of norepinephrine exposure include increased
prostaglandin-related inflammation and an immunosuppressive landscape. Conversely, increasing evidence
supports the role of aspirin use in ovarian cancer prevention and survival. Yet, key questions remain about the
underlying biological mechanism of action of chronic stress/distress and aspirin use (considering low and
standard doses separately) and their interrelationship with ovarian cancer biology. Specifically, we propose to
evaluate the hypothesis that distress enhances ovarian cancer progression by promoting inflammatory and
immune processes and that aspirin abrogates these effects. Our innovative study uses unique population-based
and experimental resources. Aim 1 will use data from four long-term prospective cohorts, a population-based
case-control study, a hospital case series that collected self-reported measures of chronic stress and distress
(e.g., depression), and ovarian tumor tissue. Aim 1 will measure gene expression in bulk high-grade serous
tumor samples (to capture the full tumor microenvironment) using whole-exome RNASeq. We hypothesize that
distress is associated with the upregulation of inflammation-related and immune suppression gene expression
pathways that are normalized among aspirin users. We will also assess if the association of distress with ovarian
cancer risk is attenuated among aspirin users. Notably, we are leveraging studies that have highly characterized
ovarian cancer cases, allowing the examination of associations between distress-related gene expression
profiles and clinical outcomes. Using an orthogonal and interactive approach, Aim 2 will use experimental ovarian
cancer mouse models to characterize the progressive effect over time of daily restraint stress on tumor
inflammation and immunity, as well as ovarian tumor growth, using RNASeq and stress hormones measured via
ELISA assays. We will also examine if aspirin (recapitulating equivalents of low and standard-dose aspirin in
humans) counteracts the effects of chronic stress on tumor progression and inflammatory and immune gene
expression networks. This project will leverage the scientific services of several cores, including the Puerto Rico
BioBank (PRBB) and the Quantitative Science Core (QSC), with substantial interaction with the Outreach Core,
the Planning and Evaluation Core, and working with trainees in the Research Education Core. This innovative
application will inform future work to develop novel immunopreventive strategies, pharmacotherapies, and
psychosocial interventions to prevent and treat invasive ovarian cancer in patients who experience chronic stress
and distress.